Project 3

ABSTRACT: PROJECT 3
Over the last several decades, it has become possible to isolate a patient’s own cells, engineer and expand them
in the laboratory, and use them to treat an existing cancer. This technology has largely advanced to using primary
human T cells genetically modified to express a tumor specific T cell receptor (TCR) or chimeric antigen receptor
(CAR). This approach has demonstrated durable cures in some leukemias, but has had limited success in the
treatment of solid tumors. This lack of efficacy is believed to be due to challenges faced by T cells in migrating
into and within complex solid tumor microenvironments and multiple immunosuppressive modalities found there.
As many of these challenges have been identified and mechanistically studied, we hypothesize that we can
engineer CAR T cells capable of overcoming all challenges found in the solid tumor microenvironment, leading
to durable cures for cancer patients with the worst prognosis. Recently, a number of groups have published high
efficiency methods for engineering T cells using CRISPR/Cas9. Moreover, the use of recombinant adeno
associated virus (rAAV) as a DNA donor molecule for homologous recombination (HR) combined with Cas9 has
also demonstrated incredible rates of site-specific gene delivery in T cells. Although these approaches are highly
effective, there are still drawbacks and issues to be resolved to improve capabilities and safety of gene editing
cells for therapy. For instance, nuclease-based gene editing still relies on stochastic repair of genotoxic double
strand breaks (DSBs) with little uniformity in the editing outcome. Fortunately, new technologies have emerged
to gene edit DNA at single base pair resolution with high product purity and efficiency and without a targeted
DSB, termed Cas9 base editors (BEs) and primer editors (PEs). We have demonstrated that this technology
allows for highly efficient multiplex genome editing via programmable enzymatic single base changes without
creating toxic DSBs, i.e. “digital editing”. As this technology is relatively new, there is also opportunity to develop
new and innovative genome editing strategies to develop fully digitally edited cells intended for therapeutic use
in a cost effect, rapid, and accurate manner. Thus, our specific aims are as follows: 1) Further develop multiplex
digital editing in murine and human T cells and explore novel uses for digital editing, 2) Deploy multiplex digital
editing to install novel edits in order to enhance T cells migration into and within mechanically complex tumor
microenvironment and also hardwire T cells to maintain a T resident memory phenotype, 3) Implement digital
editing to develop “off-the-shelf” T cells with enhanced solid tumor efficacy via digital knockout of all 3 NUR4A
transcription factor family. In summary, by deploying digital editing, we will make gene editing of cells intended
for therapeutic use more sophisticated, safe and lead to effective therapies against solid tumor tumors with
mechanically complex and immunosuppressive tumor microenvironments.

Public health relevance
NARRATIVE: PROJECT 3 Immunotherapy advances have been successful against some leukemias, but largely ineffective for treating solid tumors. We aim to use new gene editing techniques to develop T cells that will track and attack brain and pancreatic tumors, two cancers with the worst survival rates. Furthermore, we aim to develop methods to produce these T cells rapidly and cost-effectively.